Developmental Gene Expression In C elegans

Our interests are in gene regulation and developmental regulation. Over this past year, our focus has been entirely set on understanding mesodermal cell fate specification in the anterior of the animal using forward and reverse genetics in the nematode C. elegans. Anterior lineages that give rise to body wall muscle also generate sever other non-muscle cells and blast cells that undergo post-embryonic developmental fates. In teasing out the transcription factors that are both necessary and sufficient for body wall muscle specification and differentiation, we have uncovered a number of transcription factor also required for several non-muscle cell fates. Using a variety of tools and genetic approaches, we have explored various mutant and/or RNAi-mediated reduction-in-function approaches to sort out as single cell resolution how the loss of each factor, ether alone or in combination, impacts these developmental events.